Mechanism of Chemotherapy Induced Microvascular Dysfunction in Cancer Survivors

Project Abstract
Every year 255,000 new cases of breast cancer are diagnosed amounting to well over 4,000 deaths
occurring per year in U. S alone. With the use of anthracycline-based polychemotherapy (including doxorubicin),
the reduction in annual deaths from breast cancer is approximately 38% for women under 40. Systemic
Chemotherapy (CTx) plays an important role in the management of these patients; however, most CTx agents
have severe adverse consequences on the cardiovascular system. Injury to the heart as a result of exposure to
CTx is well established; however, little data exist on the contribution of CTx to endothelial cell dysfunction and
the direct effect on mitochondria in the microcirculation. Doxorubicin (DOX), a widely used CTx drug, is known
to cause excessive DNA damage, including in the mitochondria where DNA damage increases reactive oxygen
species (ROS) production. Mitochondrial dysfunction, induced by mitochondrial DNA (mtDNA) damage,
uncouples coronary blood flow from cardiac workload. Excessive mtDNA damage leads to an elevation in cell
free (cf) mtDNA which is known to act as a secondary messenger, triggering an inflammatory response in the
vascular endothelium. cfmtDNA has been observed in disease models of endothelial dysfunction and correlated
with poor clinical outcomes but not investigated on a mechanistic level or in Cardio-Oncology. The restoration of
mitochondrial integrity in the coronary microvasculature has proven to be sufficient to restore normal heart
function, yet few reports show CTx effect on mitochondrial function, and none have investigated effects in the
microvasculature. To date, no studies exist which consider the contribution of mitochondrial function and mtDNA
damage on cell survival and physiological endothelial function after CTx in human coronary vessels. We
speculate the acute effect of CTx induced mtDNA damage is further amplified by elevation of circulating mtDNA
fragments, leading to diminished vascular reactivity. As CTx is known to be more effective at damaging
cancerous cells than host and endothelial cells, elevation of mtDNA fragments after effective anticancer therapy
is a reasonable expectation. This raises the possibility that CTx-induced endothelial dysfunction may play a
key role in development of myocardial pathologies. The focus of this proposal is to define the direct signaling
events that mechanistically link CTx to microvascular endothelial damage.

Public health relevance
Project Narrative: Decreased coronary microvascular function is a recognized contributor to the development of chronic heart failure; mitochondrial DNA damage is thought to be a key component that uncouples cardiac demand from blood flow and Restoration of mitochondrial integrity is sufficient to restore physiological heart function. However, The effect of systemic anti-cancer therapy on human coronary microvascular function has not been evaluated and we hypothesize that anti-cancer therapy mitochondrial DNA damage promotes mitochondrial dysfunction (including elevated free radical production and release of mitochondrial DNA fragments) which augments therapy-induced microvascular dysfunction. The overall goal of this application is to determine the role of telomerase, specifically in the mitochondria, in maintaining coronary vasodilation during external insult by chemotherapy.